Developmental and Mentoring Core

PROJECT SUMMARY/ABSTRACT: Developmental and Mentoring Core
The goal of the HU CFAR Developmental and Mentoring Core is to catalyze cutting-edge HIV research at
Harvard and its affiliated hospitals through direct grant funding of projects that enhance the CFAR mission and
align with the research priorities of the OAR. The Core focuses on leadership development through funding
and mentoring of Early Career Investigators (ECIs) and provides developmental funding, grant writing
mentorship, and training in high-priority scientific areas to support the next generation of HIV researchers. The
foundation of the Core’s funding mechanisms is the Developmental Award, awarded twice yearly to meritorious
ECIs. To respond to developing HIV research priorities, as defined at our annual Strategic Planning Meeting
and by the OAR, the Core also releases requests for proposals to catalyze new areas of research represented
by HU CFAR Scientific Working Groups. The Core also sponsors and coordinates workshops to develop
critical new HIV research skills in areas that have included microbial genomics and computational biology,
enhancing the ability of CFAR members to engage in emerging research areas and technologies. Core
mentoring activities provide both intensive individual feedback, for example, through mock K reviews prior to
each NIH HIV/AIDS funding deadline, as well as broader community skill-building such as through the Core’s K
Writing Workshop and other CFAR-sponsored training opportunities. The mission of the Developmental and
Mentoring Core remains central to the HU CFAR, and the enormous value of this Core has been broadly
recognized at an institutional level: The Harvard Provost and the Deans of Harvard Medical School and the
Harvard T.H. Chan School of Public Health, as well as affiliated Harvard hospitals contribute funding support
for Developmental Grants that further leverage the CFAR. In the first four years of the current funding cycle, we
reviewed 115 grant applications and funded 53 (from 48 investigators), for a 46% funding rate. Fifty percent of
grantees were women, 35% were under-represented minorities, and 25% were international ECIs, primarily
from Uganda and South Africa. To continue to provide high-impact, rigorous training and mentorship for Early
Career Investigators, we propose the following Specific Aims: 1) Support high-priority, cross-disciplinary HIV
research activities at Harvard University and with international colleagues through Scholar Awards. 2) Foster
leadership development at Harvard and affiliated international sites through a mentoring program for ECI and
structured training opportunities for their mentors. 3) Grow and diversify the HU CFAR community through
formal outreach and orientation activities, linkage with Scientific Working Groups, and funding opportunities
that support diversity, equity, and inclusion.